Core D (Microscopy Core)

Project Summary – Core D
The primary purposes of Core D (the Microscopy Core) are to provide central facilities and technical assistance
for: (1) Service/Technical Assistance in the preparation, optical imaging and image analysis of cells and tissues.
In addition, Core D will design and fabricate specialized chambers, holders, etc. to facilitate live cell and tissue
imaging of adipocytes, nerves, blood vessels and immune cells in perivascular adipose tissue in Projects I-IV;
(2) Training in methods and approaches for the preparation, optical imaging and importantly image analysis of
cells and tissues both ex vivo and in vivo will be available, as needed, by Projects I-IV; and (3) Development
of new approaches and instruments to help Projects I-IV push their science forward. These Aims will be
accomplished through the personnel and equipment that comprise this core. Core D will assist PPG investigators
with routine optical imaging and image analysis of slides, as well as more sophisticated analysis such as co-
localization, deconvolution and 3-D reconstruction. Time-lapse imaging of living, cultured cells; dynamic, real-
time imaging of intracellular Ca2+ and intravital microscopy also will be accomplished in Core D. By centralizing
core techniques, Core D will enable cost efficiency because a portion of technical help and laboratory
facilities/equipment will be provided, avoiding a duplication of efforts and expenditure of money by the
investigators. In addition, by providing services, training and development for all Project personnel, Core D will
provide PPG investigators with a degree of quality-control, rigor, and reproducibility in experiments as well as
additional time with which PPG investigators can follow scientific pursuits.